Injection of autologous volar fibroblasts to the stump site to allow pressure adaptation and enhanced prosthetic use in amputees

Project Summary Abstract
The long term objective of the proposed research is to use cellular therapy to advance regenerative medicine.
In particular, we wish to help amputees who have lost a limb. While major improvements have been made to
prosthetics, the skin side of the interface at the stump site was not evolved to bear weight. The stump does not
normally have the pressure adaptive abilities of the soles of the foot for example. The present grant proposes
to biopsy, purify and expand fibroblasts from an existing palm or sole and inject them into the stump site of an
amputee to improve their use of prosthetics. We also propose to study the basic biology behind cell therapy to
understand how the injected cells change the native cells, and in turn how those native cells affect the injected
cells. The results of this grant will hopefully lead to a new therapy to help not only amputees, but potentially
prevent pressure ulcers and provide a platform for future cell therapies.

Public health relevance
Project Narrative Regenerative medicine and cell therapy hold great promise to treat disease. We propose to try to help amputees who use prosthetics but find them painful or the cause of skin problems at the stump site. To do so, we will purify and expand cells from a native palm and sole and inject them into the stump site to hopefully give the stump some of the properties of normal palms and soles such as resilient skin that is pressure adaptive.